A Novel Immune Tolerization Strategy for Investigating the Trade-offs between Oncogene Pathogenicity and Immunogenicity.

PROJECT SUMMARY
Genetic alterations triggering oncogene activation can produce neoantigens, rendering transformed cells
vulnerable to immune assault. Under heightened immune pressure these cells must balance growth with immune
evasion, offering a potential therapeutic avenue for early malignant cell targeting. However, the identification and
study of distinct alterations contributing to immune evasion independently of tumor growth is hindered by the
absence of immunocompetent models capable of separating oncogene-driven tumorigenesis from the
associated immune responses. To overcome this barrier, we developed RECON, a novel immune tolerization
strategy to convert transgenic proteins that may be recognized as “non-self” into self-antigens. RECON enables
the use of foreign elements in the context of an intact immune system via ubiquitous expression of these
elements, at the same time utilizing a dual-transcriptional/translational control system to suppress endogenous
transgene levels and activity (e.g. luminescence, oncogenic transformation). Utilizing RECON's dual transgene
tolerizing-suppressing effects on immunogenic oncogenes, we hypothesize that we can uncouple an oncogenes
pathogenic potential from its immunogenic properties, enabling for dissection of the distinct genetic and
phenotypic alterations that govern immune evasion independently of tumorigenesis during the earliest stages of
cancer pathogenesis. Understanding these molecular events will shed light on how cells expressing non-native
elements achieve enhanced immune evasion, thereby advancing our comprehension of cancer progression and
potentially exposing new therapeutic strategies for early disease targeting. RECON presents a unique
opportunity to explore oncogene-driven tumorigenesis within experimentally modified immune environments. It
stands to generate fundamental insight into the trade-offs between tumorigenicity and immunogenicity during
tumor progression and evolution. Overall, the RECON model represents a promising advancement in scientific
research, offering a versatile solution that addresses existing limitations while extending the utility of diverse
transgenic elements to various model organisms with intact immune repertoires.

Public health relevance
PROJECT NARRATIVE The proposed project aims to investigate early and critical immunoediting events in cancer pathogenesis. Employing an innovative immune-tolerization strategy capable of uncoupling oncogene-tumorigenicity and immunogenicity, this research seeks to elucidate distinct immune evasion mechanisms in the presence and absence of immune pressure. Overall, this study stands to advance our understanding of early immune evasion mechanisms in cancer tumorigenesis while potentially revealing new therapeutic targets for early disease intervention.